CORE A - BAKER

The Administrative Core will be responsible for general administrative oversight and budgetary management of the program. Centralization of these activities will promote efficient management of program resources, and will significantly facilitate communication between Project and Core Leaders. Dr. Baker , the Principal Investigator of the P01, serves as the director of this Core, and she will have primary responsibility for the overall conduct of the Program Project. The Administrative Core will provide centralized secretarial support, which will assist with scheduling of monthly program meetings of Project and Core Leaders, regular discussions and interactions with the Internal Advisory Board, External Advisory Board visits, and preparing quarterly and yearly financial reports and yearly progress reports. Dr. Baker will assist to ensure that the research performed through this Program Project is in compliance with NIH and Institutional requirements.

Public health relevance
The Core is responsible for the management of the overall Program Project. It provides the administrative structure and scientific leadership to maximize collaborative interactions and scientific exchange among Project Leaders, Core Leaders, and Internal and External Advisory Committees, as well as the necessary administrative and grants accounting support for the program project.